Acetylcholinergic Neurotransmission During Aging

Project Summary
This proposal is aimed at determining the role of changes in acetylcholinergic neurotransmission on synaptic
physiology and behavior during aging. Acetylcholine regulation has long been thought to play a crucial role in
the mediation of cognitive and behavioral function as an organism ages, yet the precise function of acetylcholine
in this process has, till date remained poorly elucidated. We are using a subtle mutation in the vesicular
acetylcholine transporter (VAChT) the protein responsible for the packaging of ACh for exocytotic release to
determine the role of cholinergic neurotransmission during aging. The short life span of the fly coupled, with
additional genetic tools unique to this system will allow us to assess the impact of altered ACh release on
behavior and synaptic physiology throughout the lifespan of the animal. Our preliminary data show for the first
time action potential firing in aged Drosophila cholinergic neurons; we also show that Vacht mutations have a
differential effect on organismal survival with the most severe mutation have a significantly shorter lifespan than
wildtype. These and other results have allowed us to advance the central hypothesis that a decrease in
VAChT function produce a corresponding decrease in neuronal excitability and behavior that are
amplified with age In Aim 1, we will determine the effect of a relatively mild reduction decrease in VAChT
function on synaptic physiology at central cholinergic synapses during aging. In Aim 2, we will measure whether
the reduction in Vacht affects cognition at defined points across the lifespan. Future studies will be aimed at
using the system that we have developed here to understand the mechanisms behind the preferential
susceptibility of cholinergic neurons in pathological conditions such as Alzheimer’s disease.

Public health relevance
Project Narrative Cholinergic dysfunction underlies the cognitive decline associated with aging, yet the exact contribution of cholinergic neurotransmission to age-related decline in behavioral performance is still poorly understood. By analyzing a hypomorphic mutant in the vesicular acetylcholine transporter (VAChT), the protein responsible for packing and transporting acetylcholine for synaptic release, we seek to determine the effects of changes in acetylcholine release on synaptic physiology and on acetylcholine-mediated behaviors like as olfactory associative learning and on the decline in these behaviors during aging. Together, these findings will set the stage for future efforts to identify small molecule agonists of acetylcholine release to treat effects of cholinergic dysfunction during aging.